"Maternal Outcome Monitoring and Support (MOMS) - A mHealth symptom self-monitoring and decision support system to reduce racial and ethnic disparities in postpartum outcomes

PROJECT ABSTRACT/SUMMARY
Severe maternal morbidity (SMM) rates have risen 120-200% in the United States in the past two decades,1
and experts estimate that 40-60% of these cases are preventable.2,3 Suicide or self-harm related to postpartum
psychiatric issues, although typically reported separately from SMM, is the second leading cause of maternal
death.4,5 There additional intensive-acute psychiatric events (IAPE) that do not result in death not reflected in
statistics of SMM. Improvement initiatives are predominantly hospital-based and rely on women recognizing
their own symptoms and seeking care without ample support or education. We hypothesize that we can
improve patients’ self-efficacy and decision-making about when to seek care by helping them to self-monitor
symptoms and by providing decision support. We propose to develop a mHealth-based, patient-reported
outcome (PRO) and decision-support system to help mothers determine when to seek care for warning signs
of SMM. Our project focuses on diverse populations facing postpartum disparities, particularly African-
American and Spanish-speaking Latina women. The long-term goal is to enable Dr. Benda to leverage this
work into an independent research program, which will design, evaluate, and implement technologies to
improve health equity. Using the robust resources of Weill Cornell Medical College and external advisors, work
in the K99 phase will develop and validate a framework of design requirements for postpartum symptom
reporting and decision-support needs. In the R00 phase, Dr. Benda will independently design, evaluate, and
pilot a mHealth PRO and decision-support tool to improve knowledge and self-efficacy for postpartum patients
in the areas of SMM and IAPE. The specific aims are to: 1) develop and refine a framework of design
requirements for postpartum symptom reporting and decision-support needs; 2) design and evaluate a
functioning prototype of MOMS/MAMA through heuristic feedback with experts usability testing with patients;
and 3) conduct a pilot trial assessing the feasibility and preliminary effectiveness of MOMS/MAMA for
improving knowledge and self-efficacy among postpartum patients at risk of SMM. To accomplish these aims,
we have assembled an interdisciplinary team with research expertise in informatics, nursing, public health,
minority health, clinical trials, and technology design and evaluation. Our team also has clinical domain
expertise in obstetrics/gynecology and psychology/psychiatry. Our proposal addresses important public health
issues (SMM and IAPE) and seeks to reduce disparities by targeting minority groups most affected by them.
Given the array of new competencies and the multidisciplinary nature of the patient-centered work, this
K99/R00 award is a necessary step to achieve the candidate’s career goal of designing technology-based
interventions to advance health equity.

Public health relevance
PROJECT NARRATIVE Severe maternal mortality and morbidity and postpartum depression are growing public health issues, which are of particular concern to minority groups, including African-Americans and Spanish-speaking Latinas. Our proposal aims to improve a patient’s ability to detect warning signs of severe maternal mortality and morbidity and postpartum depression and seek clinical care. The proposed research addresses NIMHD’s research goal of developing and testing interventions to reduce health disparities.